Inter-Brain Synchrony as a Neural Mechanism of Social Connection in Schizophrenia

PROJECT SUMMARY/ABSTRACT
Social dysfunction is a core feature of schizophrenia, and individuals with a schizophrenia diagnosis often lack
strong social ties to friends and family. This type of social disconnection is detrimental to health and associated
with reduced quality of life. However, current treatments have little to no effect on social functioning and
connectedness in schizophrenia, and new treatment approaches are urgently needed. Yet, poor understanding
of the neural mechanisms that underlie the formation and maintenance of social connections in schizophrenia
has hindered the development of novel interventions. Recent social neuroscience research has identified inter-
brain synchrony as an important neural mechanism that promotes the formation of social ties by facilitating
successful social interactions in healthy samples. Converging evidence suggests that this mechanism may be
disrupted in schizophrenia, yet it has never been investigated directly in a schizophrenia sample. This project
will investigate inter-brain synchrony and its relevance to social connection in schizophrenia for the first time,
using methods adapted from non-clinical research. In this study, participants who have a schizophrenia
diagnosis and healthy control participants will each take part in structured social interactions with two different
laboratory confederates while electroencephalographic (EEG) recordings are collected simultaneously from
both the participant and the confederate. The interaction with one confederate will include a conversation
structured to induce a feeling of interpersonal closeness (experimental condition), while the interaction with the
other confederate will include a conversation structured to include only superficial small-talk (control condition).
The amount of inter-brain synchrony between participants and confederates will be assessed based on EEG
activity from just before and after each conversation, during a brief collaborative task. This study has two major
goals. First, the project will investigate inter-brain synchrony as a neural mechanism of social dysfunction in
schizophrenia by comparing synchrony between the schizophrenia and control samples as well as
investigating relationships between levels of inter-brain synchrony and participants’ social connectedness.
Second, the project will test the malleability of inter-brain synchrony measures by comparing synchrony
between the two experimental conditions and the pre- vs. post-conversation measures. As an additional goal,
the project will investigate relationships between inter-brain synchrony and interpersonal synchrony of behavior
measured during the social interactions, and with clinical variables (e.g., symptoms). Achieving these goals
has the potential to transform the understanding and treatment of social dysfunction and disconnectedness in
schizophrenia by elucidating the role of a novel neural mechanism. This study could offer new treatment
targets for interventions to improve social functioning, and it could provide a basis for the development of novel
biomarkers to assess social functioning in schizophrenia and other mental health conditions.

Public health relevance
PROJECT NARRATIVE Schizophrenia is characterized by social dysfunction, including reductions in the number and strength of social connections to friends and family, which is linked to numerous health risks and reduced quality of life. Yet, currently available treatments have little to no effect on social functioning or connectedness in schizophrenia, and the development of better treatments is hindered by a poor scientific understanding of the neural mechanisms that contribute to these impairments. This project will investigate for the first time in schizophrenia a neural mechanism that is thought to facilitate the formation of social connections – inter-brain synchrony – in order to improve scientific understanding of the neural mechanisms of social dysfunction in the disorder, and to provide a basis for the development of new and better treatments to improve social functioning and connectedness in the illness.